Omics interrogation of functionally competent hematopoieitic stem cells

Project Summary/ Abstract
Hematopoietic cell transplantation (HCT) is a life-saving treatment for disordered hematopoiesis, including ma-
lignant and non-malignant diseases. Umbilical cord blood (CB) is a promising source of hematopoietic stem
cells (HSCs) for HCT; however, CB HCT is limited by the low HSC numbers present in single CB units. Thus,
there is a critical need to improve the functional competency and/or number of functional HSCs in each CB
unit, and treatments to enhance HCT must be improved or supplemented with new treatments. The applicant's
long-term goal is to establish himself as an independent investigator at an outstanding academic research in-
stitution where his studies will focus on identifying ways to improve HSC function for enhanced HCT, with the
goal of discovering novel therapeutic modalities to improve treatment for disordered hematopoiesis for im-
proved patient outcomes. The investigator’s immediate career objectives are to successfully complete his post-
doctoral training and transition to an independent investigator position. He will accomplish this by seeking guid-
ance from expert mentors, improving his technical scientific skillset and developing career skills important to an
independent investigator position. As an independent investigator, he will seek to provide insight into manners
to improve HSC function using omics approaches supported with cell biology, biochemistry and mouse model-
ling of HCT approaches. The goal of the associated research plan is to elucidate molecular programs that can
be targeted to enhance CB HSC function and to generate sufficient preliminary data to submit a competitive
R01 application in the final year of the award. Specifically, the research plan proposes examining combinations
of treatments known to enhance HSC function for HCT, such as Dipeptidyl peptidase 4 (DPP4) inhibition and
physioxic isolation of HSCs, to determine if these combinations are additive, synergistic, or have no further ef-
fect. The proposed study will examine transcriptomic and epigenomic changes induced by treatments known to
improve HSC function and the transcriptome of recently homed and early engrafted HSCs in a mouse model of
HCT will be analyzed compared with the pool of cells transplanted to recipient mice. This data will yield insights
into common and unique gene programs that are important for HSC function and engraftment. This study will
provide candidate genes that can be targeted by inhibition or stabilization to improve HSC function and engraft-
ment and will examine their importance using mouse models for HCT. Taken together, this approach will iden-
tify new potential treatment modalities to enhance HCT. The applicant’s strong career development plan, guid-
ance from his outstanding mentoring team, the environment at the internationally recognized top tier research
institution of Indiana University School of Medicine, and completion of the proposed aims in the research ap-
proach will prepare him for a productive and highly impactful career managing an academic lab focused on
molecular mechanisms that can be exploited to improve patient outcomes for disordered hematopoiesis.

Public health relevance
Project Narrative The proposed research is relevant to public health because it will provide insights into improving cord blood hematopoietic cell transplantation, a proven life-saving treatment for malignant and non-malignant hematologic diseases that is limited by low hematopoietic stem cell numbers in a single cord blood unit. This research plan will elucidate ways to improve cord blood transplantation by investigating cooperativity of treatments known to enhance hematopoietic cell transplantation, identifying core gene programs that regulate the function and engraftment of human hematopoietic stem cells, and exploring targeting these programs to improve hematopoietic cell transplantation. These studies will provide insight into novel molecular mechanisms to target and potential treatment modalities for enhancement of cord blood hematopoietic cell transplantation for future clinical use.